Molecular Mechanisms of Myosin-3

PROJECT SUMMARY/ABSTRACT
Our goal is to determine the molecular mechanisms of myosin-3 motors, unique kinase-myosin hybrids in the
myosin superfamily, that are involved in fundamental cellular processes including cargo transport and the
organization of the actin cytoskeleton in sensory cells. Despite their critical role in human biology, the molecular
mechanisms of myosin-3 motors are not well understood. We propose that different modes of regulation together
with different kinase substrates and binding partners determine the molecular mechanisms of myosin-3 motors.
An integrated and innovative biochemical, biophysical, cell biological and high-resolution structural approach will
be used to (i) determine the enzymatic profile and regulation, (ii) the unique structure (iii) and pathways that
control myosin-3 function and regulation in vitro and in cells. Collectively, these studies will reveal novel
mechanistic insights into the regulation of myosin-3 motors and have broad implications in the understanding of
how different myosins are tuned to organize actin networks in cells.

Public health relevance
PROJECT NARRATIVE This research program aims to advance our knowledge on myosin-3 motors, unique kinase-myosin hybrids that play crucial roles in the organization of the actin cytoskeleton in fundamental processes including hearing and vision. This research uses biochemical, biophysical, structural and cell biological approaches to understand the enzymology, regulation and interactome of myosin-3 motors. Results from this research are expected to provide detailed mechanistic insights into the role of myosin-3 motors in human health and disease.